Modulating explore-exploit biases by improving mood in adults with amphetamine use disorder

surging overdose deaths, high likelihood of relapse, and current lack of approved medication to treat the
disorder. When it comes to decision-making, individuals with MUD often prioritize drug over non-drug rewards
despite negative life consequences; in addition, they may not sufficiently “explore” all available choices to
“exploit” the best one (in other words, make the optimal choice leading to positive consequences). Therefore,
the “explore-exploit” trade-off is often dysfunctional in MUD. Decision-making imbalances in the explore-exploit
trade-off may extend well into abstinence, a period marked by a negative affective state (low mood, high
depression and anxiety, withdrawal), which in turn triggers heightened craving and subsequent drug use urges.
The insula, anterior cingulate cortex and striatum are crucial brain regions involved in explore-exploit behaviors
and affective state signaling that have also been linked to drug reward processing in MUD. We propose that
reducing negative affective state (improving mood) could help normalize explore-exploit behaviors and the
response of these brain areas in individuals currently abstinent from methamphetamine and other drugs. This
project will use a non-drug-related autobiographical memory recall to improve the mood of individuals with
MUD and measure whether it normalizes non-drug decision-making, using a functional magnetic resonance
imaging-based 3-arm bandit task and a behavioral contextual reinforcement learning task. A mixed
experimental design in n=80 (72 completers, assuming 10% attrition) allows the identification of a between
subjects
effect of positive (n=40, 36 completers) vs. neutral (n=40, 36 completers) mood modulation and
assess the within-subject impact on explore-exploit behaviors pre- versus post-mood modulation. Mood groups
will be compared on positive and negative affect, and behavioral/brain responses to reward valuation,
outcomes and learning rates. The overarching goal is to establish that improving mood in individuals with MUD
can [1] reduce their negative affective state, [2] normalize outcome sensitivity in key brain regions and
associated learning, and [3] reduce the influence of drug rewards on the valuation of non-drug rewards. This
approach of this proposal embodies the goals of the NIH RDoC Initiative and the NeuroMAP Center by
identifying an actionable disease-modifying target (mood) and studying its effect on the cognitive and neural
dysfunction underlying a specific cognitive process (explore-exploit behaviors) relevant to MUD, and possibly
other related neuropsychiatric disorders. By targeting the intertwined mechanisms between negative affect and
explore-exploit biases, innovative, effective intervention strategies for MUD may be unveiled, addressing a
critical public health challenge.